Olympus FV4000-MPE Multiphoton Microscope for Intravital Imaging

Project Summary/Abstract
In this proposal, we request funds from the Shared Instrumentation Grant mechanism for the procurement of
an Olympus FV4000-MPE Multiphoton Laser Scanning Microscope equipped with a Spectra-Physics tunable
infrared Ti:Sapphire pulsed laser. This equipment will be used to establish the first Multiphoton Intravital
Microscopy (MP-IVM) imaging facility at the University of Pennsylvania Perelman School of Medicine. This
resource will be accessible to all investigators at Penn and across the greater Philadelphia area, offered as a
service by the Cutaneous Phenomics and Transcriptomics (CPAT) Core of the Penn Skin Biology and Disease
Resource-based Center (SBDRC). Intravital microscopy, which involves the direct imaging of live mice and
other small animals, enables the visualization of tissues and cells in their natural environment. Multiphoton
microscopy is a powerful laser scanning imaging modality that has revolutionized the ability to visualize
biological processes in living organisms with high spatial and temporal resolution. Unlike conventional
microscopy, multiphoton excitation reduces light scattering, photodamage, and phototoxicity. It enables the
non-invasive study of cellular dynamics, signaling pathways, and tissue architecture in real-time. Additionally, it
offers unprecedented depth penetration, allowing for the visualization of tissue structures up to a millimeter
deep, surpassing the capabilities of traditional confocal microscopy. These attributes make multiphoton
microscopy ideal for the study of the skin and other accessible organs. This technology is rapidly becoming an
invaluable tool for studying dynamic processes such as tissue regeneration, wound healing, aging, and
disease progression. With the Olympus FV4000-MPE microscope, the new MP-IVM facility in the SBDRC
CPAT Core will be broadly available and easily accessible to investigators studying skin biology, as well as
those interested in biological processes accessible to intravital imaging, including immunology, vascular
biology, neurobiology, ocular biology, musculoskeletal biology, and stem cell biology. The research projects
outlined in this application are the product of a diverse array of NIH-funded investigators at the University of
Pennsylvania School of Medicine, each with unique expertise and research interests. They leverage the
extraordinary capability of multiphoton microscopy to visualize their cells and tissues of interest at high
spatiotemporal resolution, conducting multidisciplinary experiments. The availability of a multiphoton
microscope will significantly empower and expand the research directions of these investigators and open new
avenues of research for new users of this resource. The requested Olympus FV4000-MPE Multiphoton Laser
Scanning Microscope will be the only instrument configured specifically for mouse intravital imaging, available
on a shared-user basis for the entire University of Pennsylvania Medical School.

Public health relevance
Project Narrative This proposal aims to acquire a state-of-the-art Olympus FV4000-MPE multiphoton laser scanning microscope to establish an intravital imaging shared resource, offered through the University of Pennsylvania Skin Biology and Diseases Resource-based Center. This microscope enables the direct visualization of cells and tissues in their native, undisturbed state in live mice, revolutionizing basic and translational research that aims to expand our understanding of the pathophysiology of diseases affecting the skin and other accessible organs.